Nanodroplet Infused Analgesic-Wafer for Transmucosal Opioid-free Treatment of Subacute Oral Pain

SUMMARY
Over 2 million patients visit hospital emergency departments (EDs) each year for non-traumatic dental
conditions, accounting for 2.5% of ED visits, at a cost of $2 billion/year. Current methods for treating dental pain
in the ED or in the home do not offer long-term management of intra-oral pain (IOP). As a result, ED providers
prescribe opioids to up to 59% of the patients. To address the critical need for long-acting relief of subacute
dental pain, Centrea Biopharmaceuticals has partnered with Trekka Therapeutics and researchers at the
University of Minnesota to develop a novel transmucosal local anesthetic cocktail (LAC) encased in an advanced
“CAPRO” polymer for programmable transmucosal release (t-LAC). Here we propose to formulate t-LAC into
adhesive wafers for treatment of subacute intra-oral pain (IOP). Medical and dental providers have been urged
to replace opioids with non-steroidal anti-inflammatory drugs or local regional blocks, but these treatments show
limited efficacy for severe persistent IOP. Benzocaine, the most common topical analgesic for IOP, provides only
mild pain relief for a short duration (<30 minutes). As a result, IOP has become a gateway to opioid abuse,
misuse, and diversion, especially in adolescents and young adults. In our prior studies on post-operative pain,
injection of a 5-drug LAC provided superior analgesia than the current gold standard, Exparel® (liposomal
bupivacaine). Unfortunately, treatment of IOP via an injectable local block in the ED and in the home is limited
by availability as well as the providers’ and patients’ lack of comfort with injectable dental blocks. Therefore, we
propose to develop the t-LAC nanoparticle formulation as an easy-to-use, over-the-counter method for
programmable delivery of an efficacious drug cocktail in an adhesive, intra-oral topical wafer. Our novel topical
t-LAC wafer will extend delivery of analgesia to >12 hours with a single dose. We propose two Specific Aims to
establish the feasibility of t-LAC for delivering three drugs to manage IOP: (Aim 1) To demonstrate the in vitro
efficacy of CAPRO-based t-LAC formulations, we will load t-LAC nanodroplets onto mucoadhesive wafers and
quantify the mucoadhesive strength, dissolution rate, and drug penetration in the presence of simulated saliva
in a porcine gingival tissue model; (Aim 2) To show the feasibility of effective topical analgesia with t-LAC wafers,
we will demonstrate the in vivo efficacy and biocompatibility in a mouse model of dental pulp injury, with
comparisons to Orajel™ and plain bupivacaine. We will conduct post-mortem histopathologic studies to evaluate
local tissue inflammation following the treatments. Upon successful conclusion of our Phase I work, we will
pursue a Phase II grant to optimize t-LAC drug concentrations and pursue IND-enabling studies of efficacy,
pharmacology, toxicity, and chemistry- manufacturing-control (CMC). We ultimately will seek a major
pharmaceutical partner to commercialize the topical LAC wafers as an innovative therapy for safe, effective, and
affordable management of dental pain.

Public health relevance
NARRATIVE There is no effective topical treatment for subacute dental and intra-oral pain, for use either in Emergency Departments or in the home; thus, opioids are often prescribed, leading to opioid abuse, misuse, and diversion. We propose to develop a long-acting, programmable drug-delivery wafer for topical, localized, and sustained analgesia (>12 hours) without opioids for subacute dental pain. The proposed topical wafer, composed of a polymer-encased transmucosal Local Anesthetic Cocktail, may usher in a new standard of subacute dental pain management, unmatched in efficacy or duration by any currently available medicine.